Evaluation of an optimized intervention to prevent early substance use among American Indian youth: Examination of expanded impacts on youth and parents

PROJECT SUMMARY (See instructions):
It is imperative that we continue to innovate ways to address inequities that challenge the health and wellbeing of American Indian (AI) youth, families, and communities. The COVID-19 pandemic
disproportionately impacted Indigenous communities in the U.S. and made inequities broadly visible, but
these inequities are not new. The history of oppression of Indigenous people and attempts at cultural
eradication through federal policies and broken treaties has disrupted cultures and communities, and
research suggests that this disruption is at the root of elevated substance use problems in these
communities. AI youth initiate substance use earlier than most other youth in the U.S. and the links
between early initiation and both concurrent developmental disruption and progression to problematic
patterns of use are strong. The need for early prevention among AI youth is clear, and evidence suggests
that leveraging the cultural strengths may be a particularly effective path toward prevention. We have been
working with partners on a Northern Plains Reservation since 2009 to understand risk factors for early
initiation of substance use and to develop a culturally grounded prevention program for young adolescents.
We have developed and are testing the Thiwáhe Gluwáš’akapi (TG) program for young AI adolescents that
reinforces family, cultural and community connections. Through a multiphase optimization trial (TG1 study),
we gathered preliminary evidence of the effectiveness of TG; in a randomized controlled trial (TG2 study),
we tested the effectiveness of the optimized TG program. This project (TG3 Study) moves this work
forward through a hybrid implementation-effectiveness study. First, it will maximize what can be learned
from data collected in the TG2 study by lengthening the follow-up period for participating youth and families
to four years post-intervention and utilizing Bayesian small sample quantitative analytic methods. Second,
this study will build on what was learned in the TG2 study about program delivery to foster the transition
from research-based to community-based implementation, engaging existing community organizations to
deliver TG to families across the reservation and gathering systematic data on implementation processes
and outcomes. This study will expand our understanding of TG program effects, result in a better
understanding of the optimal fit for the sustained delivery of the TG program on the Pine Ridge Reservation
and begin developing infrastructure for long term program implementation.

Public health relevance
RELEVANCE (See instructions): Disparities in substance use and high rates of suicide pose significant risk to American Indian (AI) youth and persist despite efforts to create culturally tailored prevention approaches. This study will add to the evidence base regarding the effectiveness of a substance use prevention program tailored for AI youth and families and simultaneously examine community-based implementation of the program to identify strategies to support sustained delivery.